DEVELOPMENT OF VESIVAX CO-ADJUVANT FORMULATION OF 2E151 for flu vaccines

The contractor will generate analogues of signal modifiers and co-formulate them with monophosphoryl lipid A using the contractor’s proprietary VesiVax liposomal system.